Lens Capsule Based Extended Drug Delivery Device

PROJECT SUMMARY/ABSTRACT
Noninfectious uveitis is often managed using systemic medications or steroids. Both have undesirable side
effects. Local steroid side effects include elevated intraocular pressure, potentially requiring surgery, and
cataract formation. Systemic immune suppression has side effects that include end organ damage, certain
malignancies, and susceptibility to opportunistic infections. The long term research goal of this proposal is to
develop viable long term treatments for ocular inflammation using extended intraocular delivery of biologics and
immune modulating peptides. This aligns with the NEI priority to develop steroid therapy alternatives for ocular
inflammation without side effects such as cataracts or glaucoma. The objective of this proposal is to develop a
refillable micromachined lens capsule based drug reservoir for delivery of adalimumab via diffusion and a novel
immune modulating peptide using an encapsulated cell-based therapy. The central hypothesis is that a lens
capsule based drug reservoir will be able to safely allow extended pharmaceutical delivery to the anterior and
posterior segment of the eye. The rationale underlying this proposal is that completion will identify a new
technique of locally delivering non-steroidal based therapies for noninfectious uveitis, allowing localized long
term immune modulation with a more favorable side effect profile than current therapies. The central hypothesis
will be tested by pursuing two specific aims: 1) characterize and control the release of adalimumab from an
engineered lens capsule delivery device in vitro and in vivo; 2) characterize and control cell-based production
and release of an immune modulating peptide biopharmaceutical from within an engineered lens capsule delivery
device in vitro and in vivo. These two aims will be evaluated using an innovative approach using a
microfabricated, collapsible, and refillable intraocular drug delivery device implanted into the lens capsule
capable of delivering biologics via diffusion and peptide molecules through cell-based production.
Characterization will occur on the benchtop and after implantation into a rabbit model. The proposed research is
significant because it has the potential to provide new therapies for ocular inflammation in noninfectious uveitis
and may open new avenues for managing other chronic ocular diseases. The expected outcome of this work is
an improved understanding of how intraocular cell-based and diffusion based therapies can deliver
pharmaceuticals in ocular inflammation. These results will have an important and immediate positive impact
because they will establish a new way of treating ocular inflammation locally with extended biologic and peptide
delivery without the side effect profile of steroids. The findings of this study will provide the framework for an R01
grant with long term animal implantation testing and will prepare for human clinical testing. This work will help to
ultimately determine whether localized continuous biologic and peptide drug delivery can provide improved
clinical outcomes.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it provides characterization of two techniques to manage ocular inflammation without requiring localized steroids or systemic therapy. The proposed therapy uses an implanted microdevice to provide extended local delivery of biologics and immune modulating peptides. Thus, this proposal is relevant to the NEI’s mission that pertains to designing new therapies to restore tissue homeostasis, and of developing steroid therapy alternatives without side effects such as cataracts or glaucoma.